The ADAR Summit Meeting

ABSTRACT
The proposed renewal application seeks a second five years of funding to support the Advancing
Diversity in Aging Research (ADAR) Summit (5R13AG066389), which brings together students and principal
investigators from the successful NIA-funded MSTEM: Advancing Diversity in Aging Research (ADAR) through
Undergraduate Education (R25) programs (PAR-12-016, PAR-17-290, and PAR-20-317). ADAR programs in
MSTEM and aging were launched in 2012 with the overarching goal “to support educational activities that
encourage individuals from diverse backgrounds, including those from groups underrepresented in the
biomedical and behavioral sciences, to pursue further studies or careers in research.” This program is part of
NIA’s coordinated effort to a) fill a gap in the pipeline transitioning from undergraduate to graduate education in
aging as it relates to medicine and STEM and b) fulfill the objectives of the NIA Health Disparities Strategic Plan.
The motivation to hold annual meetings for students participating in the ADAR program is based on extensive
research demonstrating the importance of the following in retaining historically underrepresented students in
science: a) taking ownership of their research by presenting findings in a safe, non-threatening, and supportive
environment; b) creating a supportive community where students have a sense of belonging and are supported
in their identify as scientists, c) networking where students are empowered to view themselves as capable
learners through the interpersonal validation they receive from URM senior faculty and peers; d) seeing role
models of established and peer adjacent URM scholars sharing their path to becoming research scientists; and
e) participating in professional development activities. The annual ADAR Summit meets each of these criteria.
The ADAR Summit also enables students to engage in the broader scientific community, as the Summit is
held immediately before the annual meeting of the Gerontology Society of America (GSA). Partial support from
the GSA has enabled ADAR students to participate in the Presidential Symposium Poster Sessions, attend
presentations relevant to their field, and visit the Exhibition Hall, where many graduate/professional schools have
booths where students can engage with program representatives. The Summit also supports PIs to meet
annually.
The ultimate goal of the ADAR Summit conference series is to help solidify the identity of ADAR
undergraduate students as scientists in MSTEM and aging. The ADAR Summit is an important strategy for the
retention of diverse scholars in budding research careers. Ultimately, the goal is to have a research community of
scientists that is representative of the overall United States population to more accurately address health issues
of the 21st century and beyond.

Public health relevance
PROJECT NARRATIVE This proposed conference series will support an annual meeting, called the ADAR Summit, that brings together undergraduate students who are participating in an NIA-supported program to increase the pipeline of undergraduate women and underrepresented minority students who enter graduate/professional programs, and ultimately enter the scientific workforce in fields related to aging and medicine, science, technology, engineering, and math (MSTEM). Students have the opportunity to present their research, experience and participate in a national conference, discuss the graduate/professional school application process, and network with other students, established researchers, and NIA representatives, in a safe and supportive environment. This kind of experience enhances students’ identify as scientists, and increases their sense of belonging to the larger scientific community. It is hoped that such an experience will contribute to their retention in MSTEM and aging research, ultimately leading to their becoming part of the scientific workforce that contributes to the health and well-being of an increasingly diverse US population.